The Florida Node Alliance of the National Drug Abuse Treatment Clinical Trials Network

PROJECT SUMMARY/ABSTRACT
The Florida Node Alliance (FNA) aims to build on our record of success in leading and implementing trials in
healthcare settings and integrating substance use into mainstream of healthcare. We propose to bring to the
CTN the FNA’s considerable expertise in adolescent treatment, the HIV and HCV care continua in substance-
using populations, mental health comorbidities, e-Health, data science, culturalized science, health economics,
training, implementation/dissemination, and work with Hispanic populations. The FNA’s research agenda will
provide scientific leadership to develop, test, and implement interventions for the full spectrum of substance
use in adolescents and adults, and strategies for the integration of SU prevention/screening/treatment services
into mainstream adolescent and adult health care. The FNA also aims to apply our expertise in implementation
science, data science, and the use of electronic health records (EHRs) to promote learning health care
systems that build on precision medicine principles by implementing and refining methods to predict individual
response to treatment. Building on a foundation of bidirectional collaboration, the FNA proposes to develop,
test, and implement interventions that address the service delivery continuum in the FNA’s clinical and
research networks. These networks consist of SUD treatment and general medical settings, health systems,
clinical research networks, and practice-based research networks. To achieve its aims, the FNA is proposing
an innovative research agenda of concepts that (1) integrate behavioral health and family-focused
interventions in pediatric care with the use of e-technologies, (2) deliver integrative models of care for comorbid
SU and HIV in hospital settings, (3) address the comorbidities of mental health and stimulant use, (4) use EHR,
registry and environmental data to improve treatment precision, and (5) use context and culture to improve
treatment outcomes. The FNA proposes to collaborate with other Nodes on the design and implementation of
CTN trials and by providing the infrastructure and capabilities required for successful study execution. FNA
network partners have demonstrated experience in conducting point of care trials and studies that leverage the
use of EHR and claims data. The University of Miami CTSI, University of Florida CTSI, and the Georgia CTSA
will bring to the CTN the bioinformatics tools of the CTSA National Consortium. These CTSAs together with
partners of the FNA, facilitate access to a diverse patient population of 16+ million patients across numerous
settings such as primary care, EDs, hospitals, FQHCs, school-based clinics, SUD treatment, and harm
reduction venues.

Public health relevance
Project Narrative We propose to test a comprehensive, integrated hospital-based intervention to address concurrent treatment and follow-up support for people who inject drugs (PWID) and have infectious complications. Work in the current budget year will focus on site selection, development of the manuals of operating procedures, development of local standard operating procedures, national training, and site initiation/ramp-up for study launch.